EBV-Positive Diffuse Large B-cell Lymphoma: Defining Biologic Determinants of Disease Pathogenesis in Immunodeficiency

Epstein-Barr virus (EBV)-associated diffuse large B-cell lymphoma (DLBCL) represents a clinically
significant subtype often arising in immunodeficiency and defined viral latency states. Although proven in
Western populations to confer worse outcomes and greater biologic aggression, the clinical impact and
burden of disease for EBV(+) DLBCL is unknown, particularly in disparate immunodeficiency settings of
endemic Human Immunodeficiency Virus (HIV) arising in sub-Saharan Africa (SSA) versus iatrogenic
immunodeficiency in the United States (U.S.). Crucially, there is no diagnostic standard in defining EBV
positivity in DLBCL, which is essential for the pathologic diagnosis and disease categorization. The lack of
diagnostic and prognostic biomarkers of disease limits our understanding of EBV-mediated pathogenesis
and the development of much-needed targeted therapies. The overall goal of this project will be to
correlate the genomic biology of EBV(+) DLBCL to clinical variables of immunodeficiency and outcome to
improve diagnostics, uncover pathogenic mechanisms, and identify potential therapeutic targets in global
patient cohorts. The study will pursue two specific aims: 1) Define the EBV RNA and latency status of
DLBCL in disparate immunodeficiency settings using an established global cohort from SSA and the U.S.,
2) Global molecular profiling of EBV-associated DLBCL arising in immunodeficiency, using the established
cohort. Outcomes from this study will advance our knowledge in EBV pathogenesis of DLBCL across
immunodeficiencies, potentially identifying both diagnostic and prognostic biomarkers of disease and
unveil therapeutic targets. With the COBRE support, Dr. Volaric will develop the necessary skills in
bioinformatics data analysis and processing as well as global health project management and leadership
that will position her optimally to establish an independent research program. Dr. Volaric has assembled
strong mentorship and scientific advisory teams, led by her primary mentor Dr. Seth Frietze, with expertise
in EBV-mediated lymphomagenesis, multi-omics analysis, multiplex imaging, bioinformatics, biostatistics,
biorepository management, and development of global research partnerships. With the team’s guidance
and mentorship, Dr. Volaric will develop and strengthen her scientific skillsets to emerge as a leader in
global lymphoma research and collaborative partnerships.

Public health relevance
Epstein-Barr virus (EBV) is an oncogenic virus that plays a pervasive role in the pathogenesis of diffuse large B-cell lymphoma (DLBCL), causing clinically aggressive disease across disparate immunodeficiency settings of global patient populations. This project aims to comprehensively characterize the genomic profiles of EBV(+) DLBCL arising in immunodeficiency settings of sub-Saharan Africa and the United States to identify diagnostic and prognostic biomarkers and ultimately improve clinical outcomes.